Modernization and Improvement of the ONPRC Nonhuman Primate Reproductive Biomaterial Cryo-Repository

SUMMARY/ABSTRACT
The Assisted Reproductive Technologies (ART) Core at the Oregon National Primate Research Center (ONPRC)
supports a diverse research portfolio of studies conducted by internal investigators, foundation missions, and
academic and industry partners. The ART Core provides advanced technology and exceptional expertise on
nonhuman primate (NHP) gamete and ovarian follicle function, contraception, fertilization, early embryogenesis,
implantation, fetal development, reproductive toxicology, and customization of NHP genomes for biomedical
model development. NHP models of human disease are in high demand as the translational data obtained from
studies can potentially revolutionize drug discovery and disease therapy development, supporting the many
disciplines of the overall research community. Of particular relevance to this funding opportunity, the ART Core
is home to a unique and nationally recognized repository, funded by an R24 mechanism, that contains
cryopreserved biospecimens from multiple NHP species across multiple sources, which are accessible on
demand to investigators. Currently, these biospecimens are stored in liquid nitrogen (LN2) across multiple free-
standing open access containers that must be manually and diligently monitored by ART Core staff with LN2
refilled daily. Sample tracking is maintained through manual cataloguing and data entry. This type of manual
storage system makes the samples susceptible to variations in temperature, spontaneous release of the vacuum,
and samples being misidentified or lost. We therefore seek funding for a self-contained, automated cryogenic
storage system that has multiple superior features including automatic and redundant LN2 monitoring and fill,
temperature monitoring with alerts, automated sample placement and retrieval, inventory management and
documentation, barcoding of samples, and partitioning of inventory. Such a system would allow the ART Core to
ensure sample security and long-term preservation for the ONPRC/OHSU community and the larger biomedical
research community, particularly in our mission to safeguard rare and valuable biospecimens to continue support
for emerging, existing and future research programs.

Public health relevance
NARRATIVE The Oregon National Primate Research Center maintains a repository of cryopreserved nonhuman primate (NHP) biomaterial for long-term storage, future research use, and propagation of specific NHP genetic models. These specimens are currently housed in multiple free-standing liquid nitrogen open-access containers that require manual maintenance and monitoring. To enhance and modernize the current storage system, this application seeks funding for a self-contained, automated cryogenic storage and retrieval system with computer assisted sample tracking that would allow us to safely house rare and valuable biospecimens to ensure continued support of a wide array of national human health and disease research programs.